EPIDEMIOLOGY SUPPORT TASK ORDER - BASE YEAR PERIOD OF PERFORMANCE, APRIL 17, 2023 - APRIL 16, 2024 AND FOUR OPTIONAL PERIODS. PROFESSIONAL SERVICES

EPIDEMIOLOGY SUPPORT TASK ORDER - BASE YEAR PERIOD OF PERFORMANCE, APRIL 17, 2023 - APRIL 16, 2024 AND FOUR OPTIONAL PERIODS. PROFESSIONAL SERVICES